Mechanisms enabling the oral-to-systemic absorption of a microbially delivered immunomodulatory peptide

PROJECT SUMMARY/ABSTRACT
Bioactive peptides, or drugs made of small proteins, are used to treat an increasing number of human diseases.
However, the fact that almost no peptide drugs can be delivered orally limits their use. A long-term goal and
potential solution to this unmet need is the development of bioengineered probiotics – healthy gut bacteria
designed to be taken orally and deliver drugs inside the gut. This strategy has shown promise: the probiotic
Limosilactobacillus reuteri has recently been engineered to produce ShK-235, an analog of an injection peptide
currently in clinical trials for treatment of autoimmune disease. While oral ShK-235 peptide or L. reuteri alone
are ineffective in treating disease, oral L. reuteri engineered to secrete ShK-235 (LrS235) successfully treats
autoimmune arthritis in rats, circumventing the requirement for injection. Nevertheless, it is not currently
understood why the microbially delivered peptide can overcome barriers to oral delivery which the
peptide alone cannot. This information is necessary for the continued characterization, development, and
improvement of this novel drug delivery strategy. Therefore, the overall objective of this proposal is to uncover
the unique mechanisms enabling oral LrS235 to deliver ShK-235 intact into the bloodstream. The central
hypothesis is that live LrS235 adheres to intestinal mucus, where secreted ShK-235 is concentrated and
diffused between epithelial cells into circulation to exert its therapeutic effect. This hypothesis will be
tested with two specific aims, each focusing on a distinct arm of this host-microbe interaction. For both aims,
absorption studies will be performed in rats, using electrophysiology and immune cell proliferation assays as
functional metrics of drug absorption. Experiments proposed in Aim 1 will determine the microbe-intrinsic factors
necessary for absorption of ShK-235 from oral LrS235. Strains of LrS235 deficient in mucus adherence or
secretory capacity will be used to determine what properties of LrS235 govern successful absorption.
Experiments proposed in Aim 2 will determine the primary pathways by which ShK-235 from oral LrS235
permeates the gut epithelium. The permeability of microbially delivered ShK-235 across rat intestinal tissue ex
vivo will be characterized with Ussing chamber assays as well as localized in vivo using immunofluorescence
microscopy to tease apart what path microbially delivered ShK-235 takes from the intestine into the bloodstream.
The Principal Investigator’s training environment, spanning labs with expertise in probiotic engineering and
immune modulation in collaboration with experts in intestinal microscopy and absorption, is ideal for tackling this
interdisciplinary research question. The integrated training plan proposed builds experience in microbiology and
immunology and comprehensively prepares the Principal Investigator for a translational academic physician-
scientist career. Ultimately, the proposed research is broadly significant as it will provide new information to guide
novel drug delivery strategies and broaden our understanding of host-microbe interactions.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it investigates the novel use of live engineered bacteria for the oral delivery of peptide drugs, specifically for treating autoimmune disease. These investigations will enable new microbe-based drug delivery strategies, enhancing access to care with the potential to significantly advance our understanding of gut microbe behavior. Therefore, the proposed research contributes to the NIH’s mission of seeking knowledge on the behavior of living systems and applying it to reduce illness.